TRAF3 regulation in antiviral host defense

Project Summary
The induction of type I interferon (IFN-I) cytokines plays an essential role in the innate immune response to
virus infections by eliciting an antiviral gene program that facilitates the suppression of virus replication and
spread. Cytosolic detection of viral nucleic acids by germ-line encoded pattern recognition receptors (PRRs)
serves as an initial first step in activating the IFN-I response. Emerging studies however, have linked
previously unknown roles for DNA sensing PRRs in detecting aberrant DNA species of self-origin to trigger the
onset of age-related diseases, neurological disorders, and autoinflammatory conditions in the absence of
infection. Thus, there is a critical need to delineate the mechanisms by which nucleic acid sensing PRRs
control IFN-I activation to develop the next generation of therapeutics to combat viral infections as well as DNA
damage driven disease states. We have recently identified a novel cross-talk phenomenon between cytosolic
nucleic acid sensing PRRs that activate IFN-I and the non-canonical NF-κB pathway. While the non-canonical
NF-κB pathway primarily governs lymphoid organogenesis and B-cell survival and maintenance in response to
extracellular ligation of select members of the TNF receptor superfamily, our data unexpectedly revealed that
intracellular ligation of nucleic acid sensing cytosolic PRRs also resulted in non-canonical NF-κB activation by
causing the turnover of TNF receptor associated factor 3 (TRAF3), a key component of a steady-state negative
regulatory complex that persistently causes the destabilization of the non-canonical NF-ĸB inducing kinase
(NIK) which initiates signaling to the non-canonical NF-ĸB transcription factor complex. Our preliminary data
further established that TRAF3 and NIK operate as differential regulators of IFN-I activation downstream of
RNA and DNA sensing cytosolic PRRs. However, the mechanisms by which TRAF3 and NIK are controlled to
modulate non-canonical NF-κB and IFN-I activation upon nucleic acid detection by cytosolic PRRs are poorly
defined. Here we interrogated published data sets that examined TRAF3 and NIK protein interaction networks
with a goal of identifying novel candidates with the potential to modulate how the non-canonical NF-κB
pathway undergoes activation during cytosolic nucleic acid signaling and how the non-canonical NF-κB
effector, NIK cross-talks with the IFN-I signaling platform. We identify synaptosome associated protein 29
(SNAP29) as a TRAF3 interacting partner and seek to characterize how SNAP29 modulates TRAF3 function in
the context non-canonical NF-ĸB and IFN-I pathway activation. Our studies will help define new regulatory
elements that control not only antiviral host defense programs, but also immune development and age related
autoinflammatory disease states triggered by DNA damage or chromosomal instability.

Public health relevance
Project Narrative Cytosolic detection of viral nucleic acids elicits the activation of type I interferon (IFN-I) cytokines to foster an antiviral state. While a non-canonical NF-ĸB signaling pathway plays key roles in lymphoid organogenesis and B-cell homeostasis upon extracellular ligation by TNF receptor superfamily members, we unexpectedly found that intracellular cytosolic sensing of viral nucleic acids also triggers the non-canonical NF-ĸB pathway. The proposed research utilizes published data sets to identify and characterize a novel regulator of a key signaling component that coordinates cross-talk events between these two disparate pathways.